Proteomics of Cardiovascular Risk: The Multiethnic Study of Atherosclerosis

PROJECT SUMMARY
Atherosclerotic cardiovascular disease (ASCVD) and heart failure (HF) remain the leading cause of mortality in
the U.S. Despite improved therapies, the incidence of first ASCVD and HF events is still unacceptably high.
Progress in preventing and managing these conditions will require a better understanding of their novel risk
factors and biological pathways. Protein levels can serve as potent, specific, and modifiable biomarkers for
ASCVD and HF risk, guide therapy and elucidate causal pathways. Large-scale proteomic technology has
become available to scan 4,993 distinct proteins simultaneously in just 0.15 ml of plasma, using modified
aptamers as binding reagents. The overarching goal of this proposal is to apply large-scale proteomics to
patients who are free of cardiovascular disease (CVD) to improve incident ASCVD and HF risk prediction and
increase understanding of the biological pathways and mechanisms underlying the development of these
diseases. We will conduct the proteomic investigation in MESA, a well-characterized, racially diverse cohort of
6814 persons without CVD at baseline, recruited between 2000 and 2002. Now >15 years out from the initial
study visit, >800 cardiovascular events have accumulated, providing an opportunity for ASCVD and HF risk
modeling. MESA was conceived with the primary goal to study “progression of subclinical to clinical CVD, with
coronary artery calcification (CAC) as a subclinical measure of ASCVD and cardiac MR (CMR) as a subclinical
measure of HF. Thus, in addition to modeling of ASCVD and HF clinical outcomes, we will devise proteomic
risk scores for the development of subclinical ASCVD and HF and for their conversion to clinical events. We
will conduct proteomic studies at three study visits that span 10 years, to delineate longitudinal proteomic risk
trajectories and create “live” mutable risk scores. Lastly, in an exploratory aim, we will leverage MESA’s near
equal representation of men and women and its racial diversity by testing for any heterogeneity of proteomic
risk scores and biological pathways associated with ASCVD and HF, according to sex and by race. Models for
ASCVD and HF risk will be developed within MESA and then externally validated in the Atherosclerosis Risk in
Communities (ARIC) cohort. In sum, our Aims are to assay the concentrations of 4,993 plasma proteins in
6,043 MESA participants at 3 study visits spanning 10 years to: 1) improve the risk prediction of incident
ASCVD and HF outcomes and earlier subclinical disease, 2) inform the biological pathways of incident ASCVD
and HF outcomes and subclinical disease, 3) inform sex and racial differences in the biology and propensity to
develop ASCVD and HF, and 4) validate key findings in the ARIC cohort.

Public health relevance
PROJECT NARRATIVE Atherosclerotic cardiovascular disease (ASCVD) and heart failure (HF) remain the leading causes of mortality in the U.S. Currently, we do not fully understand and cannot predict why some individuals develop ASCVD and HF. We intend to apply a novel method that measures nearly 5000 proteins to discover new, potentially modifiable proteins that could help us predict cardiovascular risk and pave the way to new therapies.